FLOW CYTOMETRY INSTRUMENTATION

The purpose of this grant application is to acquire a Becton-Dickinson FACSCalibur analytical fluorescence flow cytometer and FACS Vantage SE fluorescence activated cell sorter. These flow cytometers are needed to up-grade our core Flow Cytometry Facility where the current flow cytometers are approximately 10 years old. The enhanced capabilities of the requested flow cytometers (4-6 colors; high speed cell sorting) are now required by NIH funded investigators to facilitate performance of their research projects.